The Role of m6A Binding Protein YTHDF1 in Cardiac Homeostasis

PROJECT SUMMARY
Although impressive progress has been made to reduce the burden of heart disease, the illness remains the
leading cause of death in the United States. Notably, many types of persistent heart injury can cause pathological
remodeling of the heart and progression to heart failure (HF). Our goal is to identify novel molecular pathways
responsible for such transition, since targeting them therapeutically presents an exciting opportunity to reverse
heart remodeling and improve survival. While transcriptional regulators of progression to HF have been studied
extensively, the importance of post-transcriptional regulation, such as chemical modification of messenger RNA,
has been overlooked. Recent studies recognized that methylation of mRNA in position N6 of adenosines (m6A)
was essential for the heart’s ability to adapt to stress, but the master regulator of this mechanism remains
unknown. This proposal is aimed to identify the undiscovered cardiac mediator of m6A-dependent mechanism
and elucidate how exactly m6A methylation acts to maintain homeostasis in the heart. After methylation, m6A-
modified mRNAs can be recognized by specific mRNA-binding proteins belonging to the YTH domain family
(YTHDF), of which YTHDF1 is a key member expressed in the heart. Our preliminary proteomics data from
mouse hearts show that YTHDF1 is the only member in its family to interact with the protein Hook homolog 3
(HOOK3), which binds motor proteins to activate cargo movement along the microtubules. Since
ribonucleoproteins can use microtubular routes to reach their sites of localized translation, our central hypothesis
is that YTHDF1 is critical for maintenance of cardiac homeostasis post-stress by modulating m6A-mRNA
translation through its interaction with HOOK3. To test this hypothesis, we have already generated a novel
conditional mouse model with cardiomyocyte-specific deletion of YTHDF1. In Aim 1, we will subject control and
cardiomyocyte-specific YTHDF1 knockout mice to a pressure-overload model of heart failure to define the
requirement of YTHDF1 for cardiac stress adaptation. In Aim 2, we will then perform ribosome profiling to
determine the global impact of YTHDF1 on mRNA translation and crosslinking immunoprecipitation assays to
identify its key mRNA targets in adult cardiomyocytes. Finally, in Aim 3 we will characterize YTHDF1 interaction
with HOOK3 and analyze its functional significance using a variety of exciting molecular biology techniques.
Overall, our approach is innovative because it aims to define the entirely novel function of YTHDF1 in the heart.
This proposal is also significant because it will fill knowledge gaps about the mechanism for YTHDF1-dependent
regulation of m6A-mRNA fate through our newly discovered HOOK3 interaction. The proposed study is also
significant because targeting direct effectors of mRNA processing such as YTHDF1 opens new avenues for
correcting pathological protein synthesis in the heart. Markedly, such knowledge can offer unique transcription-
independent targets for restoring healthy biology of cardiac muscle cells.

Public health relevance
PROJECT NARRATIVE Heart disease remains the leading cause of death for Americans. The proposed study will explore the novel role of a protein named YTHDF1 in the healthy and diseased heart. This work will provide new knowledge about the biology of heart muscle cells and allow for the development of new treatments for patients with heart disease.